NEW APPROACHES TO THE EARLY DIAGNOSIS/DETECTION OF RECURRENCE OF ACROMEGALY

The objective of this protocol is to assess the 24-h secretory pattern of growth hormone (GH) and GH response to glucose challenge in normal as well as untreated acromegalic patients, comparing standard radioimmunoassay measurements of GH with those made with a highly sensitive radioimmunetric assay and bioassay technique.